UTHSC RBL Administrative Supplement For Antiviral Discovery & Development

Project Summary
The University of Tennessee Health Sciences Center (UTHSC) proposes to upgrade facilities and broaden
research services in the existing UTHSC Regional Biocontainment Laboratory (RBL) located in Memphis, TN to
support internal and external investigators in basic and translational research with emerging pathogens and
select agents utilizing small animal. In Aim 1, upgrading the hardware and building automation system software
that has been in place since 2009 is our top priority with this funding opportunity and will allow the UTHSC
RBL to operate continuously well into the future. In Aim 2, we request support to expand existing infrastructure
in order to use our current facility to its design capacity with additional caging and racks. Importantly, a major
component of our plan is to upgrade our vivarium to house the Provantis Instem to provide support for preclinical
services. In Aim 3 and 4, we request equipment for whole animal imaging and immunological analyses to
strengthen our ability to meet the research service demands in terms of endpoints available to users; both
internally and externally. In summary, this proposal seeks to: (1) upgrade and replace outdated or obsolete
components of the building management system; (2) expand infrastructure for small animals other than mice,
(3) upgrade current animal imaging capabilities and dedicate one animal biosafety level 3 (ABSL3) laboratory
for the IVIS/CT imaging system, (4) enable preclinical services with a dedicate ABSL-3 area for Good Laboratory
Practice (GLP) monitoring; and (5) equipment to enable immunological analyses currently not available (elispot)
and replace an obsolete flow cytometry equipment with a spectral flow cytometer.

Public health relevance
Project Narrative The University of Tennessee Health Science Center (UTHSC) Regional Biocontainment Laboratory (RBL) supports basic and translational research that require biosafety level 3 (BSL-3) or animal BSL-3 (ABSL-3) containment. The UTHSC RBL provides a vast array of services that support the discovery and development of countermeasures for biodefense and emerging infectious agents with unmet medical needs. The proposed equipment requests (i.e., liquid chromatography coupled with triple quadrupole mass spectrometry, MACSQuant Tyto and CellVoyager CQ1 Benchtop High-Content Analysis System) and staff training will benefit our Users both internal and external.